Leading NCI Clinical Trials Network research nationally and at the City of Hope Comprehensive Cancer Center

PROJECT SUMMARY
This R50 application will support the activities of Dr. Alex Herrera as a Research Specialist (Clinician Scientist)
promoting and supporting National Cancer Institute (NCI)-sponsored clinical trials network (CTN) research, both
nationally and within the City of Hope Comprehensive Cancer Center (COHCCC). Dr. Herrera is a clinical and
translational lymphoma investigator who leads a clinical trial program focused on developing novel therapies for
the treatment of Hodgkin and non-Hodgkin lymphomas. Within the COHCCC, Dr. Herrera is the Associate
Medical Director of the Clinical Trials Office and Briskin Center for Clinical Research, Chief of the Lymphoma
Division within the Department of Hematology, and Co-Leader of the Lymphoma Disease Team. He is a national
leader in the NCI clinical trial networks as a member of the SWOG Lymphoma Committee Working Group and
the NCI Lymphoma Steering Committee and serves as the study chair/principal investigator or translational
medicine chair of several clinical trials in the National Clinical Trials Network (NCTN) and Experimental
Therapeutics Clinical Trials Network (ETCTN). Notably he is the study chair of the groundbreaking SWOG S1826
trial, the largest Hodgkin lymphoma trial conducted in the NCTN and the first NCTN collaboration between the
Hodgkin adult and pediatric cooperative groups, whose outcome is poised to change the standard of care. He is
also a national leader in Diversity, Equity, and Inclusion with a focus on reducing barriers to clinical trial
enrollment. Through this R50 award, Dr. Herrera will spearhead efforts to increase COHCCC NCI-sponsored
CTN research activities by (1) building specialized clinical research infrastructure to manage NCI-CTN trials and
grow a multidisciplinary institutional NCTN leadership team; (2) lead expansion and integration of the COHCCC
clinical research infrastructure across the regional/national enterprise to increase NCTN/ETCTN trial enrollment;
(3) enhance the diversity of participants in COHCCC clinical research, particularly to NCTN/ETCTN trials. This
application will also support expansion of Dr. Herrera's efforts toward setting the national NCI-sponsored clinical
trial network's research agenda for lymphoma, serving as the SWOG Lymphoma adolescent young adult (AYA)
liaison, mentoring junior investigators designing NCTN and ETCTN trials, and conducting practice-changing
lymphoma clinical research in the NCTN/ETCTN. This R50 award will allow Dr. Herrera to unify his research
agenda on a theme of driving, expanding, and diversifying internal COHCCC NCI-funded research, dovetailing
with expansion of his national NCI-funded research leadership.

Public health relevance
PROJECT NARRATIVE This proposal supports Dr. Alex Herrera’s effort in his leadership of City of Hope Comprehensive Cancer Center’s (COHCCC’s) NCI-funded clinical trials network research as well as his national leadership of NCI-sponsored research. As a City of Hope clinical research leader, Dr. Herrera will facilitate the expansion and integration of the COHCCC clinical trials infrastructure with the goal of enhancing contributions to NCI clinical trials network research and improving the diversity of patients enrolled to NCI-sponsored trials at City of Hope. As a national leader in NCI-sponsored lymphoma research, Dr. Alex Herrera will continue to guide the cancer research agenda for patients with lymphoma, including designing and leading practice-changing clinical trials, and mentoring the next generation of NCI-sponsored clinical research leaders with the goal of reducing the burden of lymphoma and improving survival of patients with lymphoma in the United States.